Multidisciplinary Training in the Biology of Alcohol Addiction

This renewal application is for a T32 training grant which provides support for five predoctoral and three
postdoctoral trainees in basic alcohol research at Wake Forest School of Medicine. The objectives of the
training program are to 1) provide multi-disciplinary training in the neurobiology of alcohol abuse and
addiction and 2) produce independent, productive scientists for the alcohol research community. Our
rationale for the proposed training arises from our diverse training faculty - a group of well-funded alcohol
investigators with solid expertise in basic, preclinical, and human-subjects research - who have successfully
trained young scientists within this program for over twenty-five years. Our highly collaborative and
multidisciplinary environment fosters trainees to gather the necessary skills to become independent
investigators and to operate within interdisciplinary teams that will increasingly characterize the future of
biomedical research. The alcohol research that characterizes our training environment is also highly
translational. First, virtually all of our training labs employ, examine, and publish in alcohol self-
administration; this has characterized the training program from its inception. The training program now also
spans experimental model systems from mice and rats, monkeys, individual humans, to human populations.
Finally, many of our training faculty employ overlapping experimental approaches, examine some of the same
experimental end points, and/or employ the some of the same behavioral models across multiple species. Our
training design therefore consists of both rigorous didactic instruction as well as intensive laboratory-based
research. It is augmented by a robust curriculum in career development, including teaching, grant- and
manuscript-writing courses, and ethics. There are multiple opportunities for students and postdoctoral fellows
to hone presentation skills including journal clubs, data clubs, and required research seminar presentations
both at the institution and at national meetings. As a condition for reappointment to the training program, we
require our all trainees apply for individual NRSAs (or independent private support) during their training and
to publish in peer-reviewed journals. This requirement helps sharpen grant and manuscript writing skills that
are critical in today's research environment. We also attempt to limit predoctoral trainees to less than three
years of support on the training grant. This time-limit ensures that the training grant provides support to the
best, brightest, and most productive students and fellows at Wake Forest School of Medicine. Our program
also benefits from distinct school resources that include a Clinical Translational Science Institute which offers
courses in translational research, a nationally-recognized primate center with several different populations of
monkeys including a fully pedigreed and genotyped vervet colony, and state-of-the-art imaging facilities that
can accommodate humans, non-human primates, and rodents. Finally, we partner with resident psychiatrists
and psychologists to give our students clinical exposure to current and long-abstinent patients. This enhances
their understanding of alcohol abuse disorders and grounds their research in the real world.

Public health relevance
The incidence of alcohol abuse and alcoholism remain high in the United States. This training program will supply the United States with highly trained alcohol researchers who are poised to address the serious problems presented by alcohol abuse disorders.